Towards Cervical cancer elimination: Implementation and scale-up of a single-visit, screen-and-treat approach with thermal ablation for sustainable cervical cancer prevention services in Kenya

ABSTRACT
This application is submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-23-
038 “Administrative Supplements for NCI Global Oncology Mentored Research” and proposes an
administrative supplement to our parent award R01CA258590.
Background
While prevention and treatment strategies exist for cervical cancer, it remains the leading cause of mortality
in Sub-Saharan Africa. The timely screening, early diagnosis and treatment of precancerous cervical lesions
is key in reducing the disease burden. Current treatment goals have focused on ablative methods but there
are women who require different treatment either by excision, hysterectomy, or radiotherapy. We will conduct
a mixed methods study on Kenyan women with precancerous cervical lesions who are not amendable to
ablative therapy and referred by our study for other treatment- little research is available for this group.
Women will be recruited from the parent grant TIBA clinics. We will evaluate this via the following two aims:
AIM 1: Evaluate the barriers and facilitators (health system, health care provider and client levels) in the
referral and linkage to care for women who screen positive for pre-cancerous lesions and not amenable to
ablative therapy. We shall conduct semi-structured surveys, focused group discussions and in-depth
interviews to gain information on the barriers and facilitators from the health care providers and clients.
AIM 2a: Determine the proportion of women with pre-cancerous cervical lesions and not amenable to ablation
therapy who access treatment within a four-month period.
All women who are screen-positive and not eligible for ablative therapy will be invited to participate in this
study and followed up for a period of four months to determine whether they are treated or not.
AIM 2b: Conduct flow mapping of existing referral services for women who screen positive for pre-cancer
lesions and not amenable for ablative therapy with a focus on identifying the steps that create barriers to
treatment access.
A sample of four to five women who screen positive for pre-cancer lesions but who are not amenable to
thermal ablation and health care providers will be interviewed to perform flow mapping. Barriers and
facilitators to treatment access will be catalogued during the flow mapping process
The objective of this study is to understand the bottlenecks in the cervical cancer care continuum following
referral and linkage of these women. This will form the basis of future studies that will enhance seamless
integration for women with precancerous cervical lesions referred for treatment.

Public health relevance
PROJECT NARRATIVE A proportion of women who screen positive for pre-cancerous cervical lesions will not be eligible for thermal ablation therapy, and instead need to be referred to receive treatment, which could pose a potential barrier to care because treatment cannot be received on the same day. This holds true as the TIBA project continues in reproductive clinics in Kenya. This project is significant because it aims to evaluate the barriers and facilitators to linkage to care for these screen-positive women in terms of treatment completion and the obstacles encountered while receiving treatment.